Plasticity of Innate Lymphoid Cells: Mechanisms and Biological Impact

PROJECT SUMMARY
Functional plasticity of immune cells is essential to fine-tune their responses to disparate stimuli. Although
plasticity may cause unwanted side effects, it may also be harnessed to steer immune responses towards
desired outcomes. Innate lymphoid cells (ILC) are lymphocytes devoid of antigen-specific receptors that produce
cytokines at early stages of immune responses. Based on specific networks of transcription factors and cytokine
profiles, ILC are subdivided into three subsets: T-bet+ ILC1 release IFN-γ; GATA3+ ILC2 secrete IL-5 and IL-13;
RORγt+ ILC3 produce IL-22 and IL-17. Recent studies showed that ILC are functionally plastic and heavily
influenced by changes in the microenvironment, which raises outstanding questions: 1) While human ILC are
functionally plastic in vitro, are they equally flexible in vivo and, if so, what mechanisms are involved? 2) In vivo
fate mapping studies in mice have documented ILC plasticity in steady state; what is the extent and impact of
ILC plasticity in disease models? 3) What epigenetic circuits control ILC responses to fluctuations in the
microenviroment? We will address these questions in three aims. Aim 1 presents the first demonstration of
transitional ILC subsets in human tonsils with features of both ILC3 and ILC1, which is evidence for ILC3→ILC1
conversion in vivo. We also present data indicating that the IKZF3-encoded transcription factor Aiolos is required
for transition. We will test the hypothesis that Aiolos cooperates with other transcription factors to drive human
ILC3→ILC1 conversion, using in vitro and in vivo approaches. We will perform chromatin studies of ILC3→ILC1
conversion to further define regulatory circuits and transcription factors that govern ILC3/ILC1 plasticity. Clonal
analyses of transitional ILC subsets will be employed to corroborate their homogeneity and developmental
trajectory. In Aim 2, we propose to precisely characterize ILC3/ILC1 transitional populations in the human
intestine by mass cytometry and scRNAseq, as they are not as clearly defined as those in tonsils. Moreover, we
propose in vivo mouse studies to determine whether diseases that alter intestinal microenvironment induce
ILC3/1 plasticity and, in turn, whether plasticity impacts immune responses during gastrointestinal infections and
IBD. These experiments will be carried out in Rorγt-reporter mice and in ILC3-deficient mice reconstituted with
either ILC3 or ex-ILC3. In Aim 3, we will test the hypothesis that in diseases that induce type 1 and type 3
polarizing cytokines, ILC2 in the gut and skin convert into ILC1/3. We will track ILC2 plasticity in vivo using
reporter mice and test the impact of plastic ILC2 in models of infections, IBD and skin inflammation in adoptive
transfer experiments. We will also define the regulatory elements controlling ILC2 plasticity in chromatin studies.
We hope that our expertise and leadership in the ILC field will yield an integrated view of ILC functional adaptation
in immunity.

Public health relevance
PROJECT NARRATIVE Cells of the immune system normally protect the organism from environmental threats, such as bacteria. To fine- tune immune responses to disparate pathogens, immune cells have a certain flexibility. However, a chronic inflammatory environment can excessively modify their functions, exacerbating inflammation and organ damage. We plan to investigate which situations and mechanisms induce this functional flexibility of immune cells in tonsils, gut and skin in both human and mouse, and may eventually lead to Inflammatory Bowel Disease, Skin Allergies, Psoriasis and, in general, chronic Autoimmune Diseases.